Sci-Tech-Core-001

SCIENTIFIC AND TECHNICAL CORE: PROJECT SUMMARY
The Scientific and Technical (Sci-Tech) Core integrates computing and information technologies, along with
services, funding, and training, to establish a versatile and economically viable infrastructure that promotes
groundbreaking population research, especially among junior population scientists (including both assistant
and associate professors). The landscape of technologies and data sources in the population sciences is
evolving rapidly, often outpacing the rate at which we formulate and address inquiries in population health and
demography. Our challenge lies in efficiently supporting existing research practices while effectively embracing
and sharing new advancements in both science and technology. This strategic approach aims to enhance the
mission of the PSC by incorporating and disseminating innovative research directions. The specific aims are
to: a) to maintain an advanced computing infrastructure that supports cutting-edge population-related research
conducted within the PSC; b) develop and implement efficient protocols to (1) establish effective
communication channels and statistical support among investigators working across multiple research fields;
(2) integrate innovative tools and technologies to enhance data collection, including surveys,
biomarker/anthropometric/genetic ancestry measures, and linkages to register and/or geospatial data; and (3)
implement secure data sharing practices that comply with regulatory requirements while facilitating
collaboration and data access; c) encourage active participation from the PSC research community in an
ongoing synthesis of advancement in computing technology and computational methodology; and d) enhance
research community access to shared computing resources by making all the services offered by the Sci-Tech
core available to affiliates and visitors associated with the local partnerships and sponsored research affiliation
program developed by the PSC, including access to the RDC, weekly colloquiums, and bi-weekly workshops.